Opportunities and Innovation Fund Component

OPPORTUNITIES AND INNOVATION FUND COMPONENT ABSTRACT
Investing in the next generation of researchers is essential to develop a well-trained, creative, and diverse
workforce capable of addressing the child health outcomes that are the focus of the ECHO Program and the
broader NIH agenda. The ECHO CC Opportunities and Innovation Fund (OIF) Component will manage awards
to early investigators to conduct research that will promote their career development, support innovative
projects that introduce new tools and technologies to the ECHO Program, and promote collaborations. This will
be facilitated by DCRI's extensive experience in establishing systems to solicit, collect and review scientific
applications and implementing small, efficient, impactful pediatric studies. The specific aims of the OIF
component of the ECHO CC, led by Drs. Linda Adair and Junfeng Zhang are to 1) provide infrastructure and
tools for solicitation, review, and an award process that will support research by a diverse group of early
investigators; and 2) provide support to ensure high quality study operations and timely completion and
dissemination of research results and career development for awardees. The OIF Component will effectively
manage five OIF funding cycles over seven years with two teams led by CC Faculty and highly experienced
project leaders. One team will develop scientific focus areas to guide OIF applications, prepare and widely
disseminate requests for applications (RFA), manage letters of intent and applications with high level tracking
software; organize highly qualified review panels for evaluation of applications, and work with NIH to inform
their funding decisions. The application solicitation process will include special attention to strategies to
enhance diversity among applicants. A second team will focus on the administration of funded projects,
including oversight of all aspects of compliance, effective management of budgets, solicitation and review of
progress reports from funded young investigators, and support for career development activities. The latter will
include a series of 10 OIF Networking and Development webinars each year for OIF early investigators to 1)
educate early investigators on the ECHO OIF support services available to them including the ECHO
publications committee process; working with the Data Analysis Center and other CC Components; and
opportunities for stakeholder engagement; 2) foster peer learning and collaboration through presentations of
work in progress; 3) enhance career development and grant skills including how to write successful career
development applications, develop and nurture diverse research teams and establish a research portfolio. OIF
early investigators will receive individualized support from dedicated project leaders assigned to oversee their
research protocol and identify challenges and implement solutions to overcome them.